Bioactive injectable implants for functional intervertebral disc regeneration

Intervertebral disc degeneration is strongly implicated as a cause of low back pain. Over a 10 year
period, more than 130,000 active service members received diagnoses of disc degeneration, with annual
incidence rates more than doubling during this time. Current treatment approaches are mostly conservative,
and in severe cases, patients may undergo surgical procedures such as spinal fusion, which do not maintain or
restore native tissue structure or mechanical function. Mesenchymal stem cells (MSCs) are attractive options
for cell-based therapies due to their potential for autologous harvest, expansion, and re-implantation making
them highly translational. A key challenge to successful application of MSCs for disc regeneration is the unique
biochemical and physical microenvironment cells are exposed to upon implantation. To overcome this
challenge, one strategy is preconditioning of MSCs by exposure to hypoxia, soft physical substrates and
developmentally-relevant stimuli during monolayer expansion in order to enhance their in vivo performance in
applications for disc regeneration. It has also been shown that MSCs isolated from bone marrow are highly
heterogeneous, both within and between donors, exhibiting distinct phenotypic characteristics, including
sensitivity to microenvironmental stress in culture. Aim 1 will therefore establish the in vitro preconditioning and
donor characteristics that maximize the survival and extracellular matrix production of MSCs in the oxygen and
nutrient-poor disc microenvironment. Preclinical demonstration of the long term efficacy of disc therapies with
respective to structural and functional regeneration, and alleviation of symptoms, using rigorously validated,
clinically-relevant outcome measures is critical to their successful future clinical translation. Our team recently
established a preclinical goat model of disc degeneration that recapitulates key characteristics of human disc
degeneration. Therefore, in Aim 2 we will establish the long term efficacy of a combined hydrogel and
optimized stem cell therapy to potentiate structural and functional disc regeneration, and alleviate symptoms, in
an established preclinical goat model of disc degeneration. To maximize the clinical impact of our findings we
will further refine our goat model to include progressive and clinically relevant functional, imaging, and
molecular biomarkers of pain and disability. Finally, in Aim 3 we will take an additional important step towards
clinical application of this therapy by establishing that adult human MSCs respond to preconditioning, and
undertake transcriptome-wide screening studies to identify unique molecular signatures that predispose MSCs
from certain human donors to enhanced performance and response to preconditioning.

Public health relevance
Intervertebral disc degeneration is strongly implicated as a cause of low back pain. Current therapies address symptoms but do not restore native disc structure or function. Delivery of mesenchymal stem cells (MSCs) represents a highly translational therapeutic strategy; however MSC performance in vivo is limited due to low oxygen and nutrition. The overall objective of this project is establish the long term efficacy of an optimized MSC and hydrogel therapy for restoring disc structure and mechanical function, and alleviating symptoms, using a preclinical large animal model of disc degeneration.